Genetic Influences on Infant Brain Development: Understanding the Developmental Origins of Mental Illness

PROJECT SUMMARY
Despite decades of research psychiatric disorders continue to be a leading source of disability in the United
States and across the world. A key challenge for those seeking to develop new therapeutics is that by the time
clinical symptoms of mental illness are recognized, much of the underlying pathologic brain development has
already occurred and may be irreversible. Consequently, our best hope of significantly impacting care and out-
comes in these devastating disorders is via prevention and very early intervention, which our proposed research
will help enable, by integrating genomics with longitudinal, pediatric imaging data and behavioral phenotyping to
better understand the developmental origins of mental illness. Our central hypothesis is that genetic variants
associated with psychiatric disorders increase risk by influencing early neurodevelopment and the establishment
of brain circuitry. This hypothesis is supported by several large-scale studies which performed functional genomic
characterization of loci that confer risk for multiple psychiatric disorders and revealed enrichment for genes reg-
ulating nervous system development, as well as innovative studies by our group in which we 1) discovered
variation in putative risk genes for Alzheimer's disease and mental illness are associated with brain changes at
birth, and 2) uncovered new genes and variants implicated in brain development, using GWAS. These findings
were based on cross-sectional data, collected close to birth. To more fully understand how DNA variants influ-
ence brain development in infancy and early childhood, and potential implications for future research and clinical
care, large, longitudinal studies are needed. Our proposed study will meet this need, and test our central hypoth-
esis by 1) harmonizing a rich array of genetic, neuroimaging, and behavioral data across 19 large and diverse
infant and pediatric cohorts from the U.S., Europe, South Africa, and Asia (N=6809, most with two or more
longitudinal brain scans and developmentally appropriate measures of impulsivity, anxiety, and aggressive be-
havior); 2) determining how common genetic variants, including those associated with mental illness, influence
developmental imaging phenotypes (DIPs) derived from structural MRI, diffusion tensor imaging (DTI), and rest-
ing state fMRI; and 3) identifying relationships between genetically-influenced DIPs and clinically-salient behav-
iors using powerful multivariate analysis methods. Our research team includes world thought-leaders in infant
imaging, genomic approaches to understanding complex traits, and behavioral assessment of infants and young
children, all working together as the Organization for Imaging Genomics of Infancy (ORIGIN). We are also part
of the ENIGMA consortium and will leverage the intellectual resources of this highly successful group. The ap-
plication is innovative in its focus on infancy and early childhood, longitudinal design, and in leveraging a unique
global alliance of researchers to create the largest-ever imaging genomics dataset focused on infancy and early
childhood. The proposed research will have a positive impact because it will enhance our fundamental under-
standing of how genetic factors influence brain development and lay the groundwork for a promising new line of
research focused on early intervention in individuals at high risk for developing a psychiatric disorder.

Public health relevance
PROJECT NARRATIVE The primary goal of the current application is to determine how genetic factors influence the development of brain structure and function in infancy and early childhood. Several major disorders emerge during this period, including autism and ADHD, and altered brain development at this early stage may increase risk for later-onset disorders such as schizophrenia. This project will provide new insights into the developmental origins of psychi- atric disease and inspire an exciting new line of research focused on preventing psychiatric conditions through very early intervention in at-risk individuals.